Administrative Core

Project Summary/Abstract: Administrative Core FPBCC Administration (Part I) oversees the overall management, planning, and support of FPBCC Research Programs and Core Facilities, information systems, space, and general administrative and financial management needs of the Cancer Center's mission. The FPBCC's Associate Director for Administration and External Affairs oversees the Cancer Center's administrative unit, which includes the business and finance services, Cancer Center and faculty administration support, information technology services, and facility management and maintenance. FPBCC Senior Leadership (Part II) roles include a Director and Associate Directors for Clinical Research, Basic Research, Education and Training, and Administration and External Affairs. The Senior Leadership Council meets monthly to discuss Cancer Center business and initiatives, including but not limited to: identifying translational research opportunities, faculty recruitment, clinical trial accrual, Cancer Center membership, and the distribution of Cancer Center space and other resources, training initiatives, and how best to serve the FPBCC's catchment area.